2022 Neurobiology of Brain Disorders GRC and GRS

PROJECT SUMMARY/ABSTRACT
The Specific Aims of the 2022 Neurobiology of Brain Disorders Gordon Research Conference (GRC) and Gordon
Research Seminar (GRS) are to promote dialogue among established and emerging leaders in
neurodegenerative disease focusing on Alzheimer's disease and related dementias. The Co-Chairs, Drs. Alison
Goate and Leonard Petrucelli, in consultation with past chairs, and the 2022 Vice Chairs (Drs. Karen Duff and
Christopher Shaw) have planned nine oral sessions: Session 1 - Keynote Address on the Development of Novel
Blood-Based Biomarkers for Neurodegenerative Disease, Session 2 - Genetic and Genomic Approaches to
Neurodegenerative Disease, Session 3 - Epigenetics of Neurodegenerative Disease, Session 4 - Frontotemporal
Dementia and ALS: Mechanisms, Session 5 - Parkinson's Disease: Mechanisms, Session 6 - Alzheimer's
Disease: Mechanisms, Session 7 - Tauopathies: Mechanism, & Biomarkers, Session 8 - Biomarkers: Diagnosis
and Theranostics, and Session 9 - Therapeutic Approaches. All invited speakers/discussants have confirmed
their participation, and gender and diversity-related issues are addressed as 17 of 33 accepted
speakers/discussants are women (51.5%), 5 are non-European (15%) and 5 (15%) are young investigators. 11
of the invited speakers are international (33%). The GRC will be preceded by a GRS to facilitate presentation
and discussion of frontier research by trainees. As the Chairs and Co-Chairs place the highest priority on
participation by trainees and early career individuals, short talks will be selected from submitted abstracts to
complement invited speakers. We will make every effort to increase participation of under-represented minorities
among conference participants and speakers. Conference participants will interact informally in a collegial
atmosphere and have ample free time, providing ideal settings for participants to brainstorm and establish
interdisciplinary collaborations. The significance of this GRC is to provide a unique forum for the international
community working on the neurobiology of brain disorders including Alzheimer's disease and related dementias
to discuss the latest advances and the future challenges in the field of neurodegeneration and aging related
brain disorders. The relevance of this application to public health is that the discussions will define the most
important questions in the field of neurodegenerative diseases including Alzheimer's disease and related
dementias spanning basic biology and disease mechanisms and aid the development of novel therapeutic
strategies. The long-term goal of this GRC is to provide a consistent platform for this community to meet every
two years to disseminate the most recent discoveries and formulate the most important questions concerning
the current state of the art research on age related neurodegenerative diseases.

Public health relevance
Project Narrative The Chairs have designed a highly interdisciplinary program that brings together international leaders in neurobiology of disease to promote knowledge exchange on the different cellular mechanisms that lead to neurodegeneration, in Alzheimer's disease and related disorders. The 2022 Neurology of Brain Disorders GRC/GRS will focus on important advances toward the development of novel therapeutics including molecular studies aimed at identifying novel targets, human studies focused on novel biomarkers and the development of both small molecules and biologics against novel targets to improve treatment of neurodegenerative diseases.